Targeting P2RX7 Signaling as a Biomarker for ADRD

TITLE: Targeting P2RX7 Signaling as a Biomarker for ADRD
ABSTRACT
Inflammation in the brain has been proposed to be an early predictor for a range of neurodegenerative diseases
such as Alzheimer’s disease (AD) and related dementias, Parkinson’s disease, ischemia-reperfusion injury,
epilepsy, amyotrophic lateral sclerosis, and traumatic brain injury. Identification and development of biomarkers
of neuroinflammation would permit researchers and clinicians to identify “at risk” subjects for these disorders,
evaluate severity of disease stage, and effectiveness of possible treatments. Previous work on imaging agents
to monitor neuroinflammation has resulted in sub-optimal radiopharmaceuticals that are only correlative in
nature. To overcome these limitations, we propose to target the P2X7 receptor (P2X7R) found within the central
nervous system and expressed primarily on immune cells. These receptors become activated in
neurodegenerative diseases, and are an ideal target to monitor disease progression and therapy response.
Previous efforts to develop ligands against this target have been stymied by the presence of P451L mutations
that cause dysfunctional P2X7R signaling commonly used animal models. Recent development and
characterization of a wild-derived mouse panel showed a high degree of overlap with human neuroinflammation,
which is likely due to the retention of functional P2X7R, making them an ideal tool to advance ligands against
this receptor. We hypothesize that neuroinflammation is a major initiator of neurodegenerative disease,
where P2X7 receptors play a central role; and that developing a novel PET tracer against this receptor
will enable phenotypic and therapeutic assessment during aging. Our goal is to characterize the third
generation agent (i.e. [18F]GSK1482160) in human cell based assays, and in acute and chronic
neuroinflammation models. In Aim 1, we will characterize [18F]-GSK14821604 in vitro in human iPSC derived
microglia expressing human P2X7R (hP2X7R) in the APOEE3/E3 or APOEE4/E4 to understand: a) the radioligand
depletion conditions for Ki (Aim 1.1); b) binding kinetics for kon, koff, Kd, Bmax (Aim 1.2), and Bp via saturation and
association/dissociation kinetics (Aim 1.3). To understand the role of P2X7R in acute and chronic
neuroinflammation, in Aim 2, we will use dynamic PET/CT in cross-sectional cohorts of female CAST/EiJ,
PWK/PhJ, PWK.APP/PS1 and CAST.APP/PS1 mice. Using dynamic PET/CT we will determine the role of acute
(Aim 2.2) and chronic (Aim 2.4) inflammation, where biodistribution (Aim 2.3), thus permitting allometric organ
dosimetry for first in human studies. In addition, to validate the sensitivity and specificity of this ligand, (Aim 2.5)
dynamic [18F]-GSK1482160 PET/CT at peak P2X7R expression will be conducted, allowing determination of
maximum (CAST.APP/PS1) and non-specific (CAST.APP/PS1P2X7R-/-) binding relative to homeostatic levels of
microglia (CAST/EiJ). Lastly, to establish test-retest reliability (Aim 2.6) we will repeat imaging in the same
subjects separated by 1 week. In all cases, post-mortem brains will undergo Autorad and IHC ex vivo for
confirmation. Combined these data will support first in human imaging studies in collaboration with the ADNI.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Dementia is predicted to affect more than 50 million people by the year 2050 and is a leading cause of death. However, there is no cure and more than 400 clinical trials have not proven successful. We believe that immune signaling molecules in the brain causes chronic brain inflammation; therefore, we believe that by being able to monitor the signaling proteins involved would be a viable strategy to stage and grade dementia using a unique set of human-relevant mouse models we have created in preparation for testing in human clinical trials.